Culture of tumor versus normal cells

PROJECT SUMMARY
Background: Mammalian models of cancer have been instrumental in the development of many targeted
therapies. It is, however, difficult to establish these models, such as patient-derived cell cultures (PDCC) and
xenografts (PDX). As a result, most cancer types have only a limited number of models available, which do not
accurately reflect the diversity of human cancer in real life.
Innovation: The majority of the patient-derived models were developed using untreated primary samples with
plenty of tumor tissue. The next challenge in tumor modeling will require much more difficult samples, such as
minute residual tumor foci in a patient with a partial chemotherapy response. Even though cancer is a disease
of unchecked cell growth in the body, normal cells paradoxically proliferate faster than malignant cells in cell
culture. As a result, in the majority of PDCC models, the cancer cells eventually disappear. To address the issue
of normal cell overgrowth, we are creating a tumor-specific medium (TSM) that suppresses normal cell
proliferation.
Preliminary data: As a proof-of-concept, we published twenty-five new ovarian cancer cell (OvCa) lines that
retained the molecular, histologic, and outcome features of the patient tumors.
Objectives: Our goal is to create innovative and simple culture methods that enable the creation of patient-
derived cell cultures and PDX models and develop best practices for validating these models.
Specific Aims: We are working on five major solid tumor types (lung, breast, prostate, kidney, and ovary) and
a liquid tumor (leukemia) to illustrate that our system can be adapted to culture the full spectrum of tumor types.
Aim 1: Patient-Derived Culture of Solid Tumors: We will establish patient-derived lung, breast, prostate,
kidney, and ovary adenocarcinoma cultures and compare their molecular profiles with the original patient tumor.
Aim 2) Patient-Derived Culture of Solid Tumors: We will establish patient-derived AML cultures and compare
their molecular and phenotypic profiles with the original patient tumor.
Research Strategy: We will compare the genome, transcriptome, and proteome of each cell line with the original
patient tumor, existing cell lines, and tumor datasets.
Innovation: By suppressing the expansion of normal stromal cells and normal epithelium, the TSM culture
system can maintain cancer cell lines long-term without feeder layers, drugs, or extracts.
Impact: Predicting drug activity in the clinic has always been difficult using traditional cultural models. Therefore,
having access to biologically relevant lung, breast, prostate, kidney, ovary, and AML cell lines could revolutionize
cancer drug development.

Public health relevance
PROJECT NARRATIVE Standard cancer cell lines have had an important impact on cancer research and greatly facilitated development of a variety of cancer treatments. However, new mammalian cancer culture models are difficult to establish. We developed a new cell culture system that allows us to establish cancer cell cultures that retain the accurate molecular features and patient outcome and drug response profile; in this application we propose to implement this technology and compare monolayer and organoid models and PDX from the same patient to establish best practices in the use of these models.